MEB-1170: A New Chemical Entity for the Treatment of Opioid Use Disorder

Project Summary / Abstract
Mebias Discovery, Inc. is developing a new chemical entity, MEB-1170, to treat Opioid Use Disorder (OUD) as a
maintenance medication. Currently, all of the FDA-approved medications for treating OUD (MOUD) – buprenorphine,
methadone, and naltrexone – come with liabilities (abuse potential, medication diversion, need for detoxification prior to
administration, risk of respiratory depression, etc.) and ~50% of patients discontinue treatment after 6 months.1,2 MEB-1170
is a full mu opioid receptor agonist and partial kappa opioid receptor agonist that has a unique pharmacological profile.
Specifically, it produces a robust analgesic response that is mediated through mu opioid receptors but has no abuse liability
as measured in multiple preclinical assays (conditioned place preference, intravenous drug self-administration, drug
discrimination) and no typical opioid-related adverse effects such as respiratory depression, constipation, and sedation. A
Phase 1 Single Ascending Dose study supported its safety and tolerability in healthy adult volunteers.
In the UG3 phase of the proposed research, we will complete preclinical studies in rodents and non-human primates to
evaluate the efficacy of MEB-1170 as an MOUD. We will assess the ability of MEB-1170 to reduce fentanyl self-
administration, as well as its propensity to produce respiratory depression and precipitate opioid withdrawal in opioid-
dependent animals.
In the UH3 phase, we will conduct a Phase 1 Multiple Ascending Dose clinical trial to further evaluate the safety,
tolerability, and pharmacokinetics of multiple doses of MEB-1170 in healthy adult volunteers over a 10-day regimen. In
addition, we will conduct a Phase 1b clinical study to assess the ability of MEB-1170 to reduce fentanyl-induced ratings of
drug liking and precipitate opioid withdrawal in opioid-dependent individuals with OUD who are not currently not seeking
treatment for OUD.
Our overarching goal is to develop MEB-1170 as a safe and effective MOUD to prevent relapse and facilitate long-term
recovery.
1 Montoya, I. D. & Volkow, N. D. IUPHAR Review: New strategies for medications to treat substance use disorders. Pharmacol Res
200, 107078, doi:10.1016/j.phrs.2024.107078 (2024).
2 Marsden, J. et al. Measurement-based care using DSM-5 for opioid use disorder: can we make opioid medication treatment more
effective? Addiction 114, 1346-1353, doi:10.1111/add.14546 (2019).

Public health relevance
Project Narrative The need for a more effective medication to treat Opioid Use Disorder is urgent. In this grant application we plan to develop MEB-1170 as a new and safer medication to reduce opioid misuse and to allow patients to recover.